Host Responses to the Pore-Forming Toxin Listeriolysin O

Summary
Listeria monocytogenes is a facultative intracellular pathogen responsible for the life-threatening disease
listeriosis. Although Lm produces numerous virulence factors, the secreted pore-forming toxin LLO is
indispensable for pathogenesis. LLO is secreted at all stages of the Listeria intracellular life cycle and binds to
cholesterol to form transmembrane pores. This virulence factor perforates the membrane of the Listeria-
containing endocytic vacuoles to release the bacterium into its replicative niche, the cytosol. It was recently
established that LLO also perforates the host cell plasma membrane, which promotes host cell invasion. It
remains to elucidate how infected cells maintain viability despite perforation of their plasma membranes and how
this low-grade perforation impacts the course of Listeria infection. The work performed in Aim 1 will establish
novel mechanisms that maintain viability of infected cells despite perforation of their plasma membranes by LLO.
Preliminary studies, via screening of a large siRNA library, led to the identification of novel families of host
proteins that were not previously known to repair the plasma membrane of toxin-perforated cells. The Aim 1
studies will establish the mechanisms of action of these novel proteins. Specifically, they will determine the role
plasma membrane depolarization plays in organizing calcium-dependent lysosome exocytosis, leading to the
release of cytoprotective cathepsins on the cell surface. Aim 1 will also establish a new role for the septins, a
family of cytoskeletal proteins, in plasma membrane repair. These studies will employ high-speed and super-
resolution microscopy to analyze the molecular assemblies that orchestrate plasma membrane repair. The Aim
2 studies will establish the impact of plasma membrane perforation by LLO on Listeria intracellular survival and
the innate immune response of antigen-presenting cells. We showed that transient plasma membrane
perforation by LLO triggers Ca2+ influx-dependent activation of conventional PKCs on the endosomal network, a
signaling event that is critical for Listeria phagosome escape. Aim 2 will identify the PKCs effectors by SILAC-
based quantitative proteomic approach and how they contribute to the release of Listeria into the cytosol. Plasma
membrane perforation also causes K+ efflux, which is known to activate the NLRP3 inflammasome. Aim 2 will
dissect the role of low-grade plasma membrane perforation in the maturation of antigen presenting cells to
enhance T cell immunity, in vitro and in vivo. This work is expected to broadly impact the development of vaccines
and novel therapeutic strategies for a wide range of diseases in which pore-forming toxins are employed by
pathogens.

Public health relevance
Project Narrative Listeria monocytogenes is a foodborne pathogen responsible for the life-threatening disease listeriosis. This work will elucidate novel host pathways activated by the major L. monocytogenes virulence factor, the pore- forming toxin listeriolysin O, to promote host cell invasion and to elicit protective T cell immunity. This knowledge will broadly impact the development of vaccines and novel therapeutic strategies for a wide range of diseases in which pore-forming toxins are employed by pathogens.